Melanin-Concentrating Hormone: Ancestral Role in Feeding & Sleep Regulation

DESCRIPTION (provided by applicant): In mammals, melanin-concentrating hormone (hMCH) is a key regulator of feeding behavior, energy homeostasis, and sleep. MCH was first identified in salmon in 1983 as a peptide (sMCH) that induced skin lightening. Despite numerous studies in different fish species, however, no clear effect on feeding was shown for sMCH. Last year, we found, in zebrafish and four other teleost fishes, two MCH genes: mch1 and mch2. Whereas mch1 perfectly resembles salmon sMCH, the mch2 gene and MCH2 peptide share genomic structure, synteny, and high homology with mammalian hMCH. Zebrafish MCH2, like mammalian hMCH, is expressed in a distinct population of hypothalamic neurons and is up-regulated upon fasting, suggesting a conservation of MCH2/hMCH regulation and function across vertebrates. However, while mammalian hypothalamus harbors thousands of MCH cells, zebrafish larval and adult brains contain more compact networks of 50 and 150 MCH neurons respectively. As MCH is not found in non-vertebrate models like Drosophila and C. elegans, the discovery of mch2 offers us a unique opportunity to explore MCH function in a simple amenable genetic model, the zebrafish. We propose in a first specific aim to characterize the MCH2 neurocircuit and to relate its activity to behavioral states. To do so, we will (i) analyze MCH2 neurons identity and fast neurotransmitter phenotype, (ii) study their arborization and connections, and (iii) precisely monitor their pattern of activity with a calcium-imaging assay in different behavioral conditions. As feeding and sleep behaviors are exclusive in their timing, it is critical to follow the firing patterns of the totality of the MCH neurons to distinguish potential feeding- related and sleep-on subpopulations. In the second specific aim, we will precisely investigate the behavioral influence(s) of MCH2. To do so we will use both a classic genetic approach and state-of-the-art optogenetic manipulation of the mch2 circuit. We will first (i) study how the MCH2 peptide and circuit regulate food intake, growth, and body weight. Further, (ii) using a novel multi-behavioral tracking system we will analyze a large spectrum of behaviors associated with energy unbalance, food search and consumption, such as exploration, anxiety, aggressiveness, bulimic like behaviors versus slow eating, and the hedonistic influence of food. Finally, (iii) we will investigate the ancestral role for MCH in sleep- wake regulation by analyzing the sleep architecture during normal sleep, induced sleep, and after sleep deprivation. In conclusion, zebrafish offers a unique situation as a transparent vertebrate to perform non-invasive observation and manipulation of small but complete neuronal networks. It will bring major insight to our understanding of how a same hypothalamic circuit times and regulates behaviors so distinct in their timing and their functions.

Public health relevance
PUBLIC HEALTH RELEVANCE: In the zebrafish species, we have recently identified the equivalent of a major mammalian feeding and sleep hypothalamic actor called Melanin-Concentrating Hormone (MCH). The zebrafish will help us understand how MCH can regulate food consumption, energy balance, and sleep, and thus how MCH could be manipulated to prevent feeding or sleep disorders in the general public. Narrative In the zebrafish species, we have recently identified the equivalent of a major mammalian feeding and sleep hypothalamic actor called Melanin-Concentrating Hormone (MCH). The zebrafish will help us understand how MCH can regulate food consumption, energy balance, and sleep, and thus how MCH could be manipulated to prevent feeding or sleep disorders in the general public. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS: Melanin-concentrating hormone: ancestral role in feeding and sleep regulation 65% of the adult population in the US is either overweight or obese. Alarmingly, 17% of children are also overweight. Overall, according to the World Health Organization, more than 1 billion adults throughout the world are overweight and as many as 300 million of those are obese. In addition to the high mortality and morbidity rates associated with obesity and complications of obesity, there is a huge economic burden associated with overweight or obese patients. Numerous therapeutic strategies are being developed and one of the primary targets is the orexigenic Melanin-Concentrating Hormone (hMCH) pathway. Unfortunately, metabolic medicine and research lacked a simple animal model because MCH is not found in the genome of Drosophila or C. elegans, and sMCH of fish has no clear role in feeding. For the last 7 years, several laboratories including ours have begun to use and establish Danio rerio (zebrafish) as a behavioral model. The zebrafish model has many advantages because it is inexpensive, rapidly reproducing, and molecular biology and other technical advances can be very efficiently applied. Last year (2009), our laboratory isolated mch2 from zebrafish and other teleosts and determined that it is the actual genetic and functional ortholog of the mammalian hMCH gene. This discovery gives us the unique opportunity to investigate the function(s) of MCH2 in feeding, sleep, and other behaviors in the zebrafish genetic model. We have also cloned the promoter of the MCH2 gene, embedded in a compact fragment of 5kb, allowing us to visualize and manipulate the 150 MCH2 cells of the zebrafish brain (compared to 200,000 cells in human). Here, we intend to take advantage of this specific promoter, the simple structure of the zebrafish brain and zebrafish body transparency to investigate the activity and the functions of the MCH2 neurocircuitry. To do so we will use the latest generation of Genetically Encoded Calcium Indicator (GCaMP3) and state-of-the art optogenetics approaches (ChR2 -H134R- and eNpHR3.0). Over the past three years, we have developed a novel videotracking device capable of analyzing all behaviors with locomotory phenotypes and supporting optogenetic experiments, allowing us unprecedented and unbiased behavioral analyses on individual or groups of fish. We propose to achieve the following specific aims: 1. Characterization of the MCH2 neuronal network a) MCH2 neurons identity and fast neurotransmitter phenotype b) Detailed anatomical investigation of MCH2 neural circuitry c) Linking activity of the MCH2 neurons to behavioral states 2. Genetic and Optogenetic investigations of MCH2 behavioral function(s) a) Regulation of food intake, growth, and body weight b) Regulation of feeding behavior, exploratory behavior, anxiety, and reward - Genetic Approach - Optogenetic Approach c) Regulation of sleep and wakefulness - Genetic Approach - Optogenetic Approach Completion of the experiments described herein will increase our understanding of several aspects of the Melanin-Concentrating Hormone system. The small MCH2 neuron cluster in zebrafish will help us to understand how this neurocircuit is organized and activated across 24h cycle and during specific behaviors. The analysis of the MCH2 circuit activity will shed light on how such a system can control both sleep and feeding when these two behaviors are so exclusive in their timing. Overall, the study of the MCH2/hMCH function in the regulation of feeding, sleep, anxiety, and more complex behaviors will contribute to extending basic knowledge crucial for the metabolic/neuroscience field and will open extremely appealing opportunities for low cost, high-throughput pharmacological screens with zebrafish.